Academic Career Leadership Award in Aging

Abstract
Mitochondrial dysfunction is an important causal factor in normal aging, and aging-related diseases such as
neurodegenerative disorders, Alzheimer's disease, cardiac disease, cancer, diabetes and muscle
sarcopenia. Age is the strongest risk factor of Alzheimer’s disease, and the prevalence of Alzheimer’s
disease doubles every 5 years in populations over the age of 65. The goal of this K07 Academic Career
Leadership Award is to develop a world-class Center in Aging and Mitochondrial Health at UCLA to foster
research collaborations, and to educate and train the next generation of leaders in this important field. The
proposed Center will be the first of its kind at UCLA and will be led by Dr. Ming Guo. Dr. Guo is an
established physician-scientist. She is a clinical specialist on dementia and cognitive impairment, who also
investigates roles for mitochondria in aging and neurodegenerative diseases including Alzheimer’s and
Parkinson’s disease in research realm. The Center's goals will be addressed in three aims: 1) to develop
core resources to attract interdisciplinary investigators to engage in aging-related research and to enhance
collaborative research projects, including a major effort in Alzheimer’s disease research; 2) to create a
comprehensive interdisciplinary training and mentorship program in aging and mitochondrial biology; and 3)
to serve as a local and national resource for research on mitochondrial biology in aging. The long-term
goals of the Center will be to obtain extramural funding for multi-investigator driven proposals, as well as
career development faculty grants and an institutional training grant to sustain the training of postdoctoral
scholars and geriatric research fellows. Thus the Center will be a new initiative for UCLA and will be a
beacon of excellence for investigators pursuing research into mitochondrial biology, aging and diseases of
aging, with an emphasis on Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE Capitalizing on UCLA’s unique strengths, I propose to create a new and cutting-edge Center of Aging and Mitochondrial Health, with an emphasis on Alzheimer’s disease. This will foster research activities of faculty across multiple disciplines, departments and schools at UCLA. As a collaborative effort, we will also develop new courses and educational activities on aging, aging and mitochondrial health, and Alzheimer’s disease, and mentor graduate students, postdoctoral scholars, medical fellows and junior faculty with a goal to enhance aging research capacity and increase the number of future researchers and educators in aging research including Alzheimer’s disease.